2024 Endothelial Cell Phenotypes in Health and Disease Gordon Research Conferences

Project Summary
This Gordon Research Conference (GRC), “Endothelial Cell Phenotypes in Health and Disease”, and the
accompanying Gordon Research Seminar (GRS) have the underlying hypothesis that an improved
understanding of endothelial cell phenotypes provides basic knowledge crucial to promote vascular repair and
enable tissue regeneration for the large collection of diseases with vascular dysfunction. The goals of this
conference are to therefore to address existing knowledge and communication gaps by bringing together
researchers at all levels who study endothelial cell biology and heterogeneity with those who study vascular
disease, bioimaging, and tissue engineering and regenerative medicine. Each of these fields has recently
developed novel paradigms, tools and models to bring forward this goal, and integration between the fields is
predicted to move all of them forward towards the translation of basic discoveries into clinical benefit. The GRC
Chair and Vice-Chair are leaders in the field and well-suited to organize the meeting. The Chairs will ensure
that the meeting goals are accomplished by bringing together a selected group of 150 researchers to a small,
semi-isolated site for a week, with a meeting structure designed to foster extensive discussion of largely
unpublished data, and in a venue that promotes informal interactions and networking through shared meals
and afternoon social activities that especially benefit trainees. Invited speakers were chosen based on
excellence in research, topic, and willingness to engage trainees, as well as geographic diversity and gender
balance. Participants will be chosen based on topic and demographics. Female and minority speakers have
been invited, and those groups will be encouraged to apply as participants. The GRS pre-meeting will be
organized by trainees for trainees to facilitate knowledge exchange and networking and provide them with a
peer group as they transition into the larger meeting. Together, the GRC and GRS will thereby foster lasting
interdisciplinary interactions and collaborations amongst NIH-funded and international vascular biologists to
impart a strong and lasting impact on the field whose progression is now more timely and urgent than ever,
with the growing knowledge of that vascular health is key not only for lifespan but also health span.

Public health relevance
Project Narrative The Gordon Research Conference on Endothelial Cell Phenotypes in Health and Disease, and its associated Gordon Research Seminar for trainees, will facilitate knowledge sharing on basic mechanisms of endothelial cell heterogeneity and new approaches for vascular repair and regeneration. This relatively small meeting with about 140 attendees is designed to foster networking and exchange of unpublished data to jump-start collaborations that can move the field forward, with a focus on important basic science questions and tackling urgent health issues related to vascular biology.